Modeling Inter-individual Differences to Address Pain of Sickle cell disease (MIDAS)

Project Abstract:
Sickle Cell Disease (SCD) is the most common human monogenic disorder, with 100,000 people with SCD in
the US predominantly of African descent. On average, individuals with SCD have 3 hospitalizations for severe
acute vaso-occlusive crisis (VOC) pain annually at costs of over 1 billion US dollars, but 10% of individuals with
SCD account for 50% of hospitalizations. Increased need for hospitalization is associated with high opioid use
and risk of early death. Burden of pain worsens, and chronic daily pain develops as adolescents with SCD age
to become young adults (AYAs). Given these inter-individual or between-person differences in pain, our objective
is the rigorous, longitudinal collection of whole-person health data to enable innovative computational
modeling & risk stratification of Black AYAs with SCD for high-impact pain. We took the novel approach of
clinically phenotyping AYAs with difficult-to-control pain & adverse drug effects (ADEs) for associations with
pharmacogenetic variants. We found that 84% had CYP2D6 variants linked to altered metabolic phenotypes.
We also found that the COMT genotype corresponds to pain severity & chronic pain risk in a higher proportion
of Black Americans with acute low back pain. The prevalence of significant pain variants is 7-39%, but we were
the first to report that both allele & genotype prevalence of 12 pain variants are significantly different in AYAs
with SCD compared to the general African American population. Prevalence among the 10% of Black AYAs with
SCD who are frequently hospitalized for pain is unknown. We were also among the first to conduct spatial
analysis to find US counties with more racial minorities have higher severe pain prevalence, and rurality is
associated with higher opioid prescribing. Given the US opioid epidemic and heightened concerns for fatal opioid
effects, doctors are now resistant to prescribe opioids. This places Black AYAs with SCD at increased risk for
severe pain, pain burden, ADEs, and both pain-related and racial bias. We will pursue 3 specific aims: 1. Collect
pain variants and longitudinal NIH HEAL common data elements, social determinants of health, and other
biopsychosocial data that Black AYAs with SCD and their caregivers identify as important to their lived experience
and use of pain management therapies, including opioids. We will collect data from 1000 Black AYAs with
SCD from 3 US regions. 2. Train & test a computational model of frequent hospitalization for acute VOC pain
and evaluate pharmacologic treatment efficacy. 3. Train & test predictive models to determine the age of chronic
daily pain onset for Black AYAs with SCD. Our focus on Black AYAs with SCD is responsive to their significant
inter-individual differences in pain burden, high healthcare utilization, health disparities, and racial pain treatment
bias. Our approach has great potential to help elucidate underlying biopsychosocial mechanisms of pain
occurring with pain management therapies, including opioid use. Identifying modifiable variables will accelerate
the development of evidence-based solutions toward precision pain management for AYAs with SCD and pain.

Public health relevance
Project Narrative: Burden of acute vaso-occlusive crisis (VOC) pain worsens, and chronic daily pain develops as adolescents with sickle cell disease (SCD) age to become young adults, with 10% having a disproportionately high number of hospitalizations for pain that is associated with high opioid analgesic use, higher prevalence of high impact daily chronic pain, and higher risk of early death. Our multidisciplinary team will rigorously collect longitudinal, whole- person health data, including NIH HEAL core data elements, social determinants of health, and biopsychosocial variables those who live with SCD and pain hypothesize are critical for understanding inter-individual or between- person differences in pain from SCD. We will generate a novel computational model to characterize interindividual differences in the lived pain experiences of adolescents and young adults with SCD to help elucidate underlying biopsychosocial mechanisms of pain occurring with pain management therapies, including opioid use and accelerate precision pain management for this vulnerable population.